Influence of Maternal IgA on Neonatal iNKT Cell Development and Gluten Sensitive Enteropathy.

PROJECT SUMMARY______________________________________________________________________
Early maternal-offspring interactions, such as the transfer of IgA through breast milk, are key in shaping mucosal
immunity and microbiota composition. Correlative studies suggest that individuals who were formula-fed are at
a higher risk of gluten sensitivities, underscoring the importance of maternal influence in early life. Maternal
factors may play a role the in the prevention of gluten sensitivity by promoting the development of immune
tolerance towards dietary antigens during the neonatal period. Recently, our lab has described two mouse
models of spontaneous gluten sensitive SI enteropathy (JH-/- and CD19-/-). Here, we provide pilot data
demonstrating that IgA-/- mice are uniquely susceptible to gluten sensitive enteropathy that is associated with
defects in tolerogenic iNKT cell phenotypes. We also demonstrate that gluten sensitivity in our model is a
transmissible (i.e. microbiota-dependent) phenotype, and that a lack of early life exposure to maternal IgA results
in chronic defects in tolerogenic iNKT cells. Our overarching hypothesis is that maternal IgA is essential for
the development of tolerogenic iNKT cells in the neonatal period, which suppresses gluten sensitivity
later in life. The objective of Specific Aim #1 is to test whether maternal IgA prevents the development of gluten
sensitivity in adult offspring. To do this, we will utilize breeding strategies of IgA-sufficient (IgA+/-) and IgA-deficient
(IgA-/-) dams and then cross-foster mixed litter offspring (IgA+/-, IgA-/-) between dams. Fostered offspring will then
be placed on a gluten free diet (GFD) or nutritionally matched gluten rich diet (GRD). After four weeks (when
animals are 8 weeks old), SI resident immune cells and luminal contents will be assessed through high-
parameter flow cytometry, 16S rRNA sequencing, histological analysis, and ATAC-scRNA sequencing on T cells
and iNKT cells. The objective of Specific Aim #2 is to test whether there is a critical postnatal window during
which maternal IgA reinforces a tolerogenic iNKT cell developmental program. To do this, we will colonize
germfree (GF) WT and GF IgA-/- pregnant dams with WT SIM or a species of Streptococcus isolated from our
colony. A timed cross-fostering approach will then be applied to determine the critical time window for tolerogenic
iNKT cell development. Bacterial meta-transcriptomics, flow cytometry, and RNA sequencing will then be
performed on adult offspring to explore the time-dependent impact of maternal IgA on neonatal microbial
colonization and function as well as the effects on mucosal immunity and iNKT cell development. Through these
aims, we will address a major gap in our knowledge regarding the effect of the maternal environment on the
development of gluten sensitivity later in life. Additionally, results from our experiments will identify novel
mechanisms by which maternal IgA influences immunological tolerance that could lead to novel therapeutic
strategies to prevent or treat gluten-sensitivity.

Public health relevance
PROJECT NARRATIVE_____________________________________________________________________ Early maternal-offspring interactions, such as the transfer of IgA through breast milk, are key in shaping mucosal immunity and microbiota composition. Maternal IgA may play a role the in the prevention of gluten sensitivity by coordinating gut microbial colonization to establish/reinforce tolerogenic iNKT cell development during the neonatal period. Using a series of novel models we have developed, completion of the experiments outlined in this proposal will address a critical gap in our knowledge regarding the role of the maternal environment in determining susceptibility to gluten-related disorders that could lead to novel therapeutic strategies to prevent or treat gluten sensitivity.